Cancer Epidemiology Research Program

Cancer is a major cause of morbidity and mortality in the United States and many other countries around the world. The Cancer Epidemiology Research Program (CE), directed by Xiao-Ou Shu, MD, PhD, and Martha Shrubsole, PhD, conducts high-impact research to improve the understanding of cancer etiology and identify biomarkers for cancer risk and prognosis to inform the development of effective cancer prevention strategies. The mission of CE is to create an optimal environment to facilitate the interaction and collaboration of investigators conducting cancer epidemiology research, and to train the next generation of scientists. The specific aims of CE are to: 1) identify biomarkers for cancer risk assessment and early detection; 2) identify nutrition, lifestyle, and other factors affecting cancer risk; 3) investigate biomarkers and lifestyle factors for cancer prognoses; and 4) identify factors influencing cancer incidence and mortality across different populations.
One of the key strengths of CE lies in the establishment and conduct of three large cohort studies with extensive exposure data and biospecimens obtained from 223,000 study participants. CE members also conduct large cancer case-control studies and intervention trials and play major leadership roles in the Vanderbilt DNA Databank (BioVU), which contains extensive electronic health records and DNA samples collected from ~250,000 patients. Recently, CE members helped launch the national All of Us Research Program with a goal to enroll one million participants across the US and lead its Data and Research Support Center. These resources have provided, and will continue to provide, extraordinary population-based field laboratories for scientific discoveries. CE members are at the forefront of identifying genetic and lifestyle factors and biomarkers for the risk and progression of multiple cancers, with research that has significantly advanced our knowledge of cancer etiology and contributed to the modification of multiple guidelines and recommendations for cancer prevention. Most of the research within CE focuses on cancers that are directly relevant to the Vanderbilt-Ingram Cancer Center catchment area, and involves participation by multiple segments of this population. CE members play a leadership role in multiple large cancer epidemiology consortia and direct large international studies to test scientific hypotheses that cannot be adequately investigated in US-based studies. CE hosts five NIH-funded training programs and has successfully fostered the career development of more than 10 junior investigators. There are 24 program members from six departments and two schools, with $13.5M in total peer-reviewed funding and NCI making up 67% ($9.0M). Out of 586 publications, 53% are intra-programmatic and 18% are inter-programmatic. Members also have 387 collaborative publications with investigators at other NCI-designated cancer centers.

Public health relevance
Cancer is a major cause of morbidity and mortality in the US and many other countries around the world. The Cancer Epidemiology Research Program (CE) seeks to conduct high-impact research to improve the understanding of the etiology of cancer and identify biomarkers for cancer risk and prognosis to inform the design of effective cancer prevention and control programs. The mission of CE is to create an optimal environment for promoting scientific discovery and facilitating collaboration between investigators to conduct cancer epidemiology research, and to train the next generation of scientists. This well-integrated program has four major thematic areas that are linked to the Program Specific Aims outlined below: Aim 1. Identify biomarkers for cancer risk assessment and early detection. Aim 2. Identify nutrition, lifestyle, and other environmental factors affecting cancer risk. Aim 3. Investigate biomarkers and lifestyle factors for cancer prognoses. Aim 4. Identify factors influencing cancer incidence and mortality across different populations. To accomplish these aims, CE members conduct research among populations at risk for developing cancer as well as cancer patients and survivors. Over the years, CE members have built rich population-based research resources that only a few top cancer epidemiology programs in the country can match. One of the key strengths of CE lies in the establishment and conduct of three large cohort studies, including the Southern Community Cohort Study (SCCS, W. Blot, W. Zheng and M. Shrubsole, U01CA202979), the Shanghai Women’s Health Study (SWHS, W. Zheng, UM1CA182910) and the Shanghai Men’s Health Study (SMHS, X. Shu, UM1CA173640). These studies have collected extensive exposure data and biospecimens from nearly 223,000 participants, providing extraordinary population laboratories to test a large range of hypotheses related to cancer epidemiology, genetics and etiology. CE members also play a leadership role in multiple large international consortia and direct the Data and Research Support Center for the national All of Us Program, with an aim to enroll one million participants across the US (J. Denny, U2COD023196). This large national cohort will provide extraordinary opportunities for many significant research studies for years to come. Many CE members use data from the Vanderbilt DNA biobank (BioVU) for epidemiologic research, including multiple cancer genome-wide association studies (GWAS). The BioVU, initiated in 2007, contains genomic DNA samples linked to the de-identified electronic health records (EHR) from approximately 250,000 patients who have sought medical care at Vanderbilt. This resource provides exceptional opportunities to conduct genetic and pharmacogenomic studies of cancer. The scientific value of these population resources will continue to grow with the extended follow-up of the three large cohort studies and the recruitment of additional study participants to the All of Us Program and BioVU. This positions CE strongly for future growth in research and training programs. CE members will continue to develop new research methodologies and apply a wide range of methods and cutting-edge technologies in large-scale epidemiologic studies. Another major focus of CE is to train the next generation of elite researchers and leaders in cancer epidemiology research. CE members lead five NIH training grants and sponsor biweekly Epidemiology Grand Rounds, workshops, research retreats, journal clubs, and working group meetings to facilitate collaborations. The Program provides a rich environment to foster the career development of junior investigators. Currently, there are 24 CE members, representing six departments/divisions across Vanderbilt University Medical Center (VUMC), Vanderbilt University (VU) and Meharry Medical College (MMC). This group of highly productive investigators brings to CE a wide range of expertise and experience from population research to clinical and basic sciences and creates a vibrant environment for interactions and collaborations. CE is co-led by Xiao-Ou Shu, MD, PhD and Martha Shrubsole, PhD, both of whom have extensive experience in conducting cancer epidemiology research. They are each leaders in their respective research areas, with complementary expertise and research foci. Their joint leadership is essential for the success of CE.